The Center on Causal Data Science for Child Maltreatment Prevention (the CHAMP Center)

SUMMARY/ABSTRACT – OVERALL
In 2019, US state and county child protection investigators determined that 656,000 children were exposed to
maltreatment by their caregivers. This number likely underestimates the true number of maltreated children by
a considerable margin. Maltreatment exposure can disrupt psychobiological systems essential for a child’s
health and adaptive functioning and result in debilitating outcomes such as post-traumatic stress, depression,
self-destructive and violent behavior, risk-taking, and substance abuse. Yet only a small proportion of those
children at risk have benefited from decades of research to acquire the scientific knowledge to prevent
maltreatment exposures and their significant consequences. This proposal seeks to enable larger-scale
preventative results through an integrated scientific program designed to address the central barrier limiting the
scale of results: available preventative interventions are insufficiently guided by robust scientific
knowledge on the complex etiologies of maltreatment exposures and their consequential outcomes.
The Center on Causal Data Science for Child and Adolescent Maltreatment Prevention (CHAMP Center) is
proposed to enable the achievement of larger-scale results by: 1) applying state-of-the-art causal data science
methods to several large, relevant, existing data sets to determine the complex etiologies for several
categories of maltreatment exposures (e.g., sexual abuse, physical abuse, neglect) and maltreatment-related
outcomes (e.g., post-traumatic stress disorder, depression, self-destructive behavior, substance abuse,
functional impairments); 2) translating this knowledge into specific decision support tools for practitioners in
the child services system to personalize interventions that precisely target etiological factors; and 3) conducting
a proof-of-concept field trial on this form of decision support. Through the integrated work of its two projects
and three cores, the CHAMP Center will establish processes to discover and translate scientific knowledge on
complex etiologies of maltreatment and its consequences and disseminate knowledge and tools for large-scale
prevention of maltreatment exposures and their devastating consequences in children at risk.

Public health relevance
NARRATIVE The Center on Causal Data Science for Child and Adolescent Maltreatment Prevention (CHAMP Center) is proposed to substantially increase the scale of preventing maltreatment and its devastating consequences for many children at risk. The CHAMP Center will achieve these results through an integrated program of scientific discovery and translation, focused on determining the causal factors producing maltreatment exposures and outcomes and both testing and disseminating strategies for targeted, personalized, and precise interventions.